Administrative Core

Project Summary/Abstract – Administrative Core
The goal of Center for Advancing Point of Care Technologies (CAPCaT) in Heart, Lung, Blood, and Sleep
Disorders is to develop and optimize novel point-of-care and home-based technologies to improve the
diagnosis and management of heart, lung, blood and sleep (HLBS) disorders. In order to achieve this goal,
strong program oversight and appropriate leadership are needed to effectively manage the resources of the
CAPCaT Technology Research and Development Center (TRDC). The overall role of the Administrative Core
is to function as a managing component and provide scientific leadership, organizational structure, effective
collaboration, and communication for all aspects of the Center. This structure is necessary to provide the
appropriate scientific and fiscal oversight of the CAPCaT TRDC; promote interactions within the Center, including
with an External Advisory Committee (EAC), and between the Center and the Point of Care Technology
Research Network (POCTRN), especially the Coordination and Technology Support Center (CTSC); and
communicate and manage stakeholders, including users, innovators, healthcare providers, researchers, health
systems and funders. The Administrative Core will have the primary responsibility for interactions with NIH staff,
including working with NIH to advance national efforts to improving the diagnosis and management of HLBS
disorders. The Specific Aims of the Administrative Core are to develop an administrative structure to select,
support and guide technology development; and promote efficient collaboration and communication within
CAPCaT, with the CTSC, and broader stakeholder community.